NYR-Diabetes Research Center (NYR-DRC)

Abstract
The primary mission of the Translational Research Core (TRC) is to support and promote high-quality
diabetes translational research. The TRC accomplishes this through efficient delivery of services including
access to gold-standard measures, consultation, technical support and training, and mentoring in clinical
research methods specifically applicable to diabetes and related metabolic disorders. The TRC serves a
wide spectrum of New York Regional Diabetes Research Center (NYR-DRC) research through broad
expertise of Core personnel encompassing investigators with proficiency in mechanistic studies, integrative
physiology, clinical trials of diabetes and obesity, and in application of new diabetes technologies. Einstein
is one of only five centers to be awarded both a DRC and a P30 Center for Diabetes Translation Research
(CDTR), which provides resources to support behavioral and community-based implementation research,
highlighting our expertise and commitment to diabetes research. The TRC’s main focus is on clinical
physiology, metabolism and diabetes therapeutics (“T1-T2” translational research), however it provides vital
services to investigators across the research spectrum including those in the New York Regional CDTR,
creating opportunities to bring translational diabetes research “full circle”. The unique strengths of the TRC
in the next project period will position us to promote continued growth of diabetes-related translational
research at the Albert Einstein College of Medicine (Einstein) and to continue to successfully integrate
leading diabetes investigators at the Icahn School of Medicine at Mount Sinai (Sinai) and Weill Cornell
School of Medicine (Cornell), as well as other regional partners, as described in the Overview of this
application. The three key features of the TRC in this renewal are: 1) continuation of the TRC’s historical
mission to provide consultation and technical services to support clinical physiology, clinical trials and cohort
studies; 2) expansion of the NYR-DRC partnership with additional TRC expertise and services and 3)
enhanced collaboration with CDTR investigators and cores to create and leverage synergy between these
two centers. The TRC provides resources through direct faculty consultation, direct access to core services
and technology, and access to trained TRC personnel to assist with crucial aspects of human research
protocol implementation.

Public health relevance
Relevance There is a clear need to more rapidly “translate” basic science discoveries related to diabetes pathophysiology into improved treatment and management strategies for patients. The Translational Research Core provides an important resource to fosters the bi- directional integration of basic research, patient-oriented research, and population-based research.